Regulation of endothelial function and vascular integrity by neddylation

Project summary
Compromised function of endothelial cells (ECs) is a root cause of various vascular diseases. While endothelial
homeostasis is known to be governed by multiple epigenetic and transcriptional mechanisms, the involvement
of post-translational modifications has been largely overlooked. Neddylation is a reversible post-translational
modification that attaches one or more ubiquitin-like NEDD8 moieties to substrates via a NEDD8-specific E1-
E2-E3 enzymatic cascade. Emerging evidence shows that neddylation plays significant roles in metabolic
disorders, cardiomyopathies, immunity, and other pathophysiological events. However, its role in the
endothelium and vascular diseases is unclear. The goal of the proposed research is to establish the
pathophysiological significance of neddylation in endothelium and to identify key downstream effectors in ECs.
The research team uncovered a link between neddylation perturbations and vascular diseases in humans and
mouse models. The team further showed that EC-specific inhibition of neddylation by deleting NEDD8 activating
enzyme-1 (NAE1) in adult mice causes mortality from pronounced vasculopathy and multi-organ damage
characterized by loss of EC integrity, cell death, inflammation, and hemorrhage. The research team hypothesizes
that protein neddylation and NAE1 downstream target cullin-3 (CUL3) protect endothelial homeostasis and
integrity by maintaining EC identity, promoting mitophagy, constraining EC cell death, and resolving stress
response signaling. Aim 1 will test the hypothesis that neddylation protects endothelial integrity by sustaining EC
identity and preventing EC cell death. Aim 2 will test the hypothesis that CUL3 functions downstream of
neddylation to promote mitophagy and fine-tune the stress response signaling, thereby maintaining EC
homeostasis. EC-specific knockout and knockin mouse lines will be used to determine the physiological
importance of neddylation and this specific target in several vascular beds. Bulk RNA-sequencing, single-nucleus
RNA-sequencing with lineage tracing, and quantitative multiplex proteomics will be performed to probe the role
of neddylation and its target in the EC transcriptome, proteome, EC trans-differentiation, and EC-other cell type
communications in multiple organs. Sophisticated biochemical and cellular assays will be carried out to elucidate
how neddylation and its target control endothelial to mesenchymal transition, mitochondrial function, and
integrated stress response in ECs. Rescue experiments in vitro and/or in vivo will be performed to establish the
cause-and-effect relationship. Successful completion of this research will provide a comprehensive mechanistic
understanding of protein neddylation in safeguarding endothelial function and integrity. This is a key step toward
the research team’s long-term goal to establish the clinical relevance of its findings and develop novel therapeutic
strategies to precisely modulate protein neddylation for vascular diseases with minimized adverse effects.

Public health relevance
Project Narrative Impaired endothelium function has a substantial role in the pathogenesis of various vascular disease that pose significant challenges to United States public health and economy. The goal of this proposal is to investigate the functional importance of protein neddylation in protecting endothelium function by sustaining endothelia cell (EC) identity, preventing EC cell death, promoting mitochondrial fitness, and resolving stress response signaling mainly through its downstream mediator cullin-3. The acquired new knowledge will provide new targets for developing therapeutic approaches to restore endothelial function with therapeutic implications for a wide range of vascular disease states.